Unraveling transcriptomic and functional changes to immune sensing neuronal ganglia in response to allergy and bacteria

Project Summary
Allergies affect millions of Americans and are exacerbated by bacterial infection. Despite mainstay therapies that
suppress immune responses to allergy or bacteria, these health issues continue to persist. An unexplored target
for new therapies lies with neural surveillance and regulation of immunity. However, this neural influence is
poorly understood and seemingly paradoxical: immune responses are exacerbated in allergy, but in response to
bacterial infection, the neural response reduces inflammation. How might this happen?
One possibility is that the peripheral neural-immune sensing apparatus might be altered by such factors as
immunoglobulin profiles, and gender, implying the participation of sex hormones. We hypothesize that such
variables affect the transcriptome and thereby the excitability of the vagus and carotid bodies. Studies in AIM 1
will use single-cell RNAseq analysis of vagal and carotid body ganglia from male and female mice with asthma,
pneumonia to identify how these nerves are changed in response to each condition. Then, we will assess nerve
activity in response to immunoglobulin stimuli of each ganglia using state-of-the-art electrophysiological
recording techniques. This project will reveal which neural cluster (vagus vs. carotid body) is the predominant
sensory ganglia involved in regulating allergic vs. bacterial immune responses and how sex may affect neuro-
immune signalling. Studies in AIM 2 will utilize DTR (diphtheria toxin receptor) technology in mice to selectively
ablate cells where DTR expression is driven by TRPV1 (transient receptor potential vanilloid 1) or TH (tyrosine
hydroxylase). Use of these transgenic mice will allow ablation of either vagal (TRPV1-DTR) or carotid body (TH-
DTR) centers by direct neural microinjection of diphtheria toxin (DTX) into vagal or carotid body ganglia using
saline injections as control. We will then expose mice to either allergen or bacterial infections. DTX injections will
selectively abolish neuronal function and reveal which ganglion is the predominant neuro-immune sensor in the
specified condition in male and female mice.
These data will: 1) identify how the response to allergic or bacterial stimuli alters receptor gene expression in
order to identify the phenotypic switch from anti- to pro-inflammatory neural-immune signalling; 2) establish a
model and sex differences that will set the stage for further investigation involving targeted knockdown within
neuro-immune sensing ganglia to discern function; 3) validate our models and methods for future investigations
into the role of neural-immune sensing in disease states.

Public health relevance
Project Narrative The nervous system plays a prominent role in immunity by sensing substances released from immune cells in response to allergens and bacteria. However, our understanding of the neuro-immune interplay is not clear; current information suggests that the neural response to allergens augment and worsen allergy, whereas in response to bacteria nerves are beneficial and temper the immune response to reduce inflammation. The goal of this proposal is to begin to investigate how allergens and bacteria alter neural responses, the mechanism behind this change, and which are the most prominent neural clusters involved in allergic and bacterial sensing.